Synaptic Organizers: Dynamic Regulation of Trans-synaptic Bridges

PROJECT SUMMARY
Synaptic organizers form macromolecular bridges that span the cleft of synapses, the contact and
communication points between neurons. Defects in many different synaptic organizers are implicated in
neuropsychiatric disorders like schizophrenia (SZ), autism spectrum disorder (ASD), and intellectual disability
(ID), illnesses in dire need of better medications. Synaptic organizers regulate the formation and function of
synapses, but their molecular mechanisms are not well understood. They likely produce a code that helps wire
billions of neurons together into neural circuits that are discrete and specific, yet also plastic, such as those
regulating human behavior. We are leveraging the neurexin (NRXN) family of synaptic organizers, and their
many partners, as prototypes to understand how trans-synaptic bridges are formed and shape synaptic
connections. Defects in NRXNs and their partners are implicated in SZ, ASD and ID. Working model: When
NRXN trans-synaptic bridges malfunction, fundamental synaptic processes change and lead to the pathology
of severe mental illness. Mounting evidence suggests that the trans-synaptic bridges formed between
NRXNs and their partners are dynamically controlled via a portfolio of different mechanisms that either
boost them or suppress them. It is not known on a molecular level how these different regulatory mechanisms
exactly work to control the formation and/or function of NRXN-mediated trans-synaptic bridges, or the bases of
their dynamic action. We hypothesize that NRXNs and their partners form a molecular platform that is
targeted by a set of fundamentally different and dynamic regulatory mechanisms, exploiting: 1) protein
3D conformational changes; 2) regulators with opposite functions; 3) the oligomeric status of partners;
and 4) factors secreted by astrocytes. In this proposal, we will determine the underpinnings of key
mechanisms, first establishing the molecular ground rules using structural, biophysical, and biochemical
techniques, and then strategically interrogating these rules in a cellular context and in in vivo studies.
Collectively, our results will reveal how regulatory mechanisms mold NRXN trans-synaptic bridges,
impacting their ability to regulate synapse formation and synaptic communication. This proposal is significant
because in addition to revealing molecular mechanisms that regulate a very large portfolio of trans-synaptic
bridges and their functions, it will also reveal protein interactions that can be targeted to manipulate specific
synaptic connections for therapeutic purposes and address specific CNS disorders. This proposal is
conceptually innovative because it propels an emerging paradigm shift that trans-synaptic bridges, like those
formed between NRXNs and their partners, are in fact subject to intense regulation by other interacting
proteins, including other synaptic organizers, and these synergize together to shape synaptic connections. This
proposal is also technically innovative because it involves using electron tomography to image flexible
synapse-organizing molecules, for which we are actively developing methodologies.

Public health relevance
PUBLIC HEALTH RELEVANCE The synaptic organizers, neurexins and their partners, play a central role in severe neuropsychiatric disorders including autism spectrum disorder and schizophrenia. These proteins constitute a suite of molecules that regulate synapse development, either by forming trans-synaptic bridges or by dynamically regulating these bridges. Elucidating the mechanisms of these molecules will reveal how they guide synapse development, shape neural circuits and regulate circuit plasticity, as also will lay the foundation to investigate highly innovative, mechanism-based therapies that target specific synapses and select circuits to ameliorate CNS disorders.